Developmental Therapeutics

The overarching goal of Developmental Therapeutics (DT) Program is to develop and translate novel
mechanism-driven anticancer therapeutics and therapeutic combinations. To accomplish this goal, Program
members conduct convergent and impactful scientific research that aims to: 1) uncover new cancer
vulnerabilities and develop novel therapeutics and combinations; 2) understand and overcome therapy
resistance; and 3) facilitate clinical translation of program-developed drugs and therapeutic strategies through
innovative clinical trials. To catalyze the realization of our Aims, DT Program pursues two other important
missions. First, DT Program is fully integrated with our Community Outreach and Engagement (COE) component
to address the etiology and molecular mechanisms underlying the major health disparities in COE-prioritized
cancers and ensure incorporation of community perspectives into our program research. Second, by actively
engaging in all facets of education and mentoring coordinated through the CRTEC (Cancer Research Training
and Education Coordination) Core, DT Program emphasizes mentoring junior members, and educating and
training the next generation of basic and clinician scientists to develop expertise across the continuum of
anticancer therapeutic development with a diverse and inclusive team.
DT Program is co-led by Dr. Dean Tang, an expert on studying (cancer) stem cells, cancer heterogeneity
and plasticity, and therapy resistance, and Dr. Igor Puzanov, an expert on conducting clinical trials with an
emphasis on combining immune and targeted agents. With complementary expertise, the Program leaders work
together to define priorities for Institutional investment, strengthen Program science by promoting intra- and inter-
programmatic collaborations, and foster Program development via retreats, the bi-weekly DT seminar series,
monthly Faculty Grant Forum, and Program funding mechanisms that emphasize COE and cancer disparities.
The DT Program presently has 42 members from 10 departments. In the current funding cycle, DT Program
members demonstrated synergistic and significantly increased productivity in basic discovery and translational
and clinical cancer research. The high impact of DT Program research is best evidenced by the quality of our
members' publications: 28% are in high-impact (JIF≥10) journals compared to 9% in 2018. Further, the direct
peer-reviewed funding in DT Program has substantially increased from $5.58M (40% from NCI) in 2018 to
$12.88M (78% from NCI) as of 3/31/2023. Notably, 78% of the members have peer-reviewed funding and DT
Program has seen significant increases in team science, health disparity focused and mentored/training grants.
Also, the Program-related clinical trial accruals have been steady and strong with a slight increase (from 346 in
2018 to 399 in 2022). Finally, DT members have contributed to the CCSG mission by not only conducting
impactful science and winning competitive grant support but also providing leadership as Shared Resource
Directors, TRG (Translational Research Group) Directors, Faculty Mentors, and leaders in education.